Chronic stress-induced cardiovascular effects are decreased by a cortical-brainstem neural circuit

Project Summary
Chronic exposure to stress is a risk factor for the leading cause of global mortalities, cardiovascular
disease. Although chronic stress alters our physiological stress response, the biological mechanisms
responsible for cardiovascular disease development remain unclear. Therefore, this proposal addresses this
substantial health problem by determining the neural basis of the cardiovascular stress response and
investigating a prospective avenue to alleviate physiological insults caused by chronic stress. Human imaging
studies have revealed the prefrontal cortex is a key site for processing stress-related information. Within the rat
prefrontal cortex, the infralimbic area (IL) is critical for behavioral and physiological stress reactivity.
Interestingly, brain stimulation studies targeting this shared cortical area in humans and rats see a
vasodepressor effect. Further, stimulating IL neurons in male rats protects against cardiovascular deficits
caused by chronic stress. To determine the biological pathways involved, we explored downstream IL
pathways and identified IL inputs to the rostral ventrolateral medulla (RVLM). Because the RVLM initiates the
sympatho-adrenomedullary stress response, an IL-to-RVLM circuit may underlie a crucial link between stress
appraisal and sympathetic reactivity. Preliminary studies found that stimulating the IL-to-RVLM circuit during
novel restraint stress blunts corticosterone release in male and female rats. Further, gene expression analysis
revealed chronic stress exposure increases brainstem catecholamine-synthesis transcripts in both sexes.
Because RVLM catecholamine neurons drive sympathetic outflow, we hypothesize that IL input may reduce
sympathoexcitation by inhibiting RVLM catecholamine activity, thereby reducing the cardiovascular
consequences of chronic stress. (Aim 1) To determine the role of the IL-to-RVLM circuit during chronic
stress, intersectional genetics will be used to reduce IL-to-RVLM signaling and measure catecholamine
synthesis enzyme expression after chronic stress, in males and females. By using fluorescent in situ
hybridization coupled with immunolabeling, mRNA expression changes of catecholamine synthesis enzymes
would clarify how chronic stress alters neurogenic-driven sympathetic activity in male and female rats and the
necessity of the IL-to-RVLM circuit for chronic stress neural adaptations. (Aim 2) Next, we will determine if
optogenetically stimulating the IL-to-RVLM circuit alleviates the cardiovascular sensitization caused by chronic
stress. By measuring real-time hemodynamics and electrocardiography during acute stress, we can assess if
stimulating IL-to-RVLM signaling reduces sympathoexcitation and cardiovascular hyperreactivity caused by
chronic stress. Results from these experiments will examine neural pathways responsible for cardiovascular
stress responding and identify chronic stress-induced changes that can contribute to pathologies and disease.
Moreover, these experiments will determine if this circuit could represent a target to safeguard cardiovascular
health against the deleterious consequences of chronic stress.

Public health relevance
Project Narrative The physiological burden of responding to repeated and prolonged daily stressors is linked to cardiovascular disease risk. Autonomic responses to chronic stress are regulated by neural pathways that can maladapt and produce physiological insults that promote cardiovascular disease. This project aims to understand how the neural circuit regulating sympathetic stress responding becomes dysfunctional after chronic stress and if it can be corrected.